Understanding the impact of AAK1 on T cell chemokine receptor expression and chemotaxis

PROJECT SUMMARY/ABSTRACT
T cells infiltrating into the brain directly and indirectly promote neuronal impairment in a wide variety of
neuroinflammatory diseases, including dementia, multiple sclerosis (MS), and epilepsy. Thus, limiting T cell
infiltration into the central nervous system could have therapeutic benefit for these patients. Adapter protein 2
associated kinase 1 (Aak1) was recently identified as an important regulator of T cell chemotaxis into inflamed
tissues in an in vivo forward genetic screen. The primary objective of this project is to understand how AAK1
regulates T cell chemotaxis, with a secondary goal of establishing the translational potential of AAK1 as a
therapeutic target in neuroinflammatory diseases. These goals will be accomplished in two aims. Aim 1 will
determine if AAK1 regulates chemokine receptor expression on the T cell surface using primary T cells. Aim 2
will define the extent to which AAK1 regulates T cell chemotaxis using in vitro migration assays and in vivo T
cell trafficking into the brain using the Theiler’s murine encephalomyelitis virus (TMEV) model of MS. This
proposal has several innovative aspects, including generation of a novel, T cell specific Aak1 knockout mouse,
validation of Aak1 as a genetic regulator of T cell infiltration, functional and mechanistic testing of a novel Aak1
mutant construct, and evaluation of Aak1 as a novel therapeutic target to limit T cell chemotaxis into inflamed
tissue. Successful completion of this project will broadly benefit many disease settings, as findings can easily
be translated to other inflammatory conditions where recruitment of T cells drives pathogenicity and may lead
to better treatments of immunologic diseases.

Public health relevance
PROJECT NARRATIVE/LAY SUMMARY A better understanding of the relationship between Adapter Protein 2 Associated Kinase 1 (AAK1) and T cell migration would be highly beneficial in a variety of disease settings where designing therapeutics to modulate T cell infiltration could benefit patients. This is especially true in neuroinflammatory settings, where infiltrating T cells directly and indirectly contribute to disease symptoms. The proposed work is high-risk, high-reward because establishing AAK1 as a novel regulator of T cell migration would provide the rationale necessary for continued development of AAK1 as a therapeutic target in neuroinflammatory diseases.